Understanding eosinophilic esophagitis-mediated inhibition of esophageal cancer

Project Summary
With a 5-year survival rate of <20% and substantial lack of response to the current standard of care, esophageal
squamous cell carcinoma (ESCC) is among the deadliest malignancies worldwide. Notably, patients with the
food-allergen-mediated inflammatory disease eosinophilic esophagitis (EoE) fail to develop esophageal cancer
according to recent epidemiological studies. Our own publication recently used mouse models of EoE and ESCC
to demonstrated that EoE limits carcinogenesis in vivo. Based on our own published and preliminary data, we
hypothesize that EoE activates anti-tumor responses in the esophagus to limit ESCC carcinogenesis. We will
test this hypothesis by: Determining the functional role of senescence in EoE-mediated suppression of ESCC
(Aim 1); determining the impact of IL-13 on esophageal epithelial cell fate (Aim 2); and defining the direct impact
of EoE upon the cellular landscape of ESCC esophageal mucosa and associated inflammatory cells (Aim 3).
These studies provide the first investigation of the direct mechanisms through which EoE can suppress
esophageal carcinogenesis. Ultimately, we aim to leverage these mechanisms to develop novel approaches for
prevention and therapy of ESCC. As allergic inflammation has been reported to be negatively associated with
various types of cancer, our findings may have significant implications in the field of cancer biology field. The
work outlined in this application will further provide the PI with a comprehensive scientific research experience
encompassing discovery and subsequent target validation in the field of cancer biology. The research component
of the proposal coupled with the detailed training plan will support the PI as she pursues her goal of becoming
an independent investigator at a top academic research institution.

Public health relevance
Project Narrative Despite a well-established negative correlation between allergy and cancer risk based upon epidemiological studies, rigorous scientific testing of the functional and mechanistic relationship between allergy and carcinogenesis as proposed in this application represent a significant knowledge gap. Leveraging of allergy- associated alterations in tissue biology to improve cancer patient outcomes has great potential for substantive clinical and translational impact.